Targeting SMARCA2 in SMARCA4-deficient lung cancers in vivo

PROJECT SUMMARY/ABSTRACT
Genomic alterations in SMARCA4, which encodes for the ATPase subunit of SWI/SNF chromatin remodeling
complexes, are found in ~10% of non-small cell lung cancers (~20,000 new cases in the US for 2024), particularly
in lung adenocarcinomas (LUAD). SMARCA4 alterations are strongly associated with metastasis, inferior
responses to targeted therapies, and poor overall survival. We and others have shown that SMARCA4 is a bona
fide lung tumor suppressor as its loss-of-function promotes malignant transformation, tumor progression, and
metastasis. However, SMARCA4-altered LUAD currently lacks effective therapeutic strategies. SMARCA2, a
SWI/SNF subunit that compensates for SMARCA4 function in its absence, is a leading therapeutic target for
SMARCA4-deficient lung cancer. Genetic disruption of SMARCA2 inhibits the proliferation of cancer cells
deficient in SMARCA4 function, but not of cells with intact SMARCA4. These findings led to the development of
selective proteolysis targeting chimeras (PROTACs), e.g. degraders, for SMARCA2. However, in vivo studies
investigating the mechanistic impact of SMARCA2 degradation on tumor progression are largely missing. This
is an urgent unmet need because SWI/SNF complexes have highly dynamic epigenetic functions that are
dependent on cellular and tissue context. I have developed genetically engineered mouse models (GEMMs) that
faithfully capture the pathologic and molecular features of human SMARCA4-deficient LUAD, and extensively
characterized the epigenetic states that arise in the absence of SMARCA4 during tumor evolution. These
GEMMs provide a powerful preclinical system to mechanistically evaluate SMARCA2 degradation as a
therapeutic approach and understand its impact on SWI/SNF function, cell state, and lung cancer progression.
Our central hypothesis is that SMARCA4 loss results in distinct cell-intrinsic molecular features and cell-extrinsic
alterations in the tumor microenvironment that dictate the responses to SMARCA2 degradation in vivo. In Aim 1,
we will assess the effects of SMARCA2 degradation on SMARCA4-deficient lung cancer progression by treating
our SMARCA4-deficient LUAD GEMMs with selective and potent SMARCA2 degraders and measuring efficacy
and cell state changes that arise upon treatment. In Aim 2, we will determine the mechanisms that underlie the
synthetic lethal relationship between SMARCA2 and SMARCA4 by mapping and integrating SWI/SNF activity,
chromatin state, and transcription in tumor-derived cell lines from our GEMMs and by performing targeted genetic
screens to identify persistence/resistance mechanisms. In Aim 3, we will harness the tumor immune
microenvironment to develop effective combinatorial approaches to target SMARCA4-deficient LUAD and
leverage patient samples to identify the molecular and cellular features of patients that may benefit from
combination treatments. Our studies will provide a comprehensive understanding of SMARCA2 as a therapeutic
target in SMARCA4-deficient LUAD, elucidate potential persistence/resistance mechanisms, and identify the
most effective and clinically translatable combination approaches for this lethal molecular subtype of lung cancer.

Public health relevance
PROJECT NARRATIVE SMARCA2 is a leading therapeutic target for SMARCA4-altered non-small cell lung cancer, a molecular subtype of lung cancer that is strongly associated with shorter time to metastasis, inferior responses to available therapies, and very poor patient survival. This proposal aims to determine the mechanistic basis for SMARCA2 as a therapeutic target in SMARCA4-altered lung cancers, identify persistence/resistance mechanisms to SMARCA2-focused therapies, and develop effective combination approaches using genetically engineered mice faithfully modeling SMARCA4-altered lung cancer and patient-derived samples. Altogether, these studies will advance our understanding of SMARCA2 as a targeted therapy for SMARCA4-altered lung cancer and may improve patient outcomes long-term.